Developmental Research Program

Developmental Research Program
ABSTRACT/DESCRIPTION
The purpose of the Developmental Research Program of the MSKCC SPORE in Soft Tissue
Sarcoma is to support innovative translational research projects in sarcoma. The translational
research projects in this program aim to use knowledge of animal and human sarcoma biology
to develop and test interventions related to improving diagnosis, prognosis, and treatment of
patients with soft tissue sarcoma. This program will allow us to respond quickly to new
opportunities in translational research and will help us recruit new scientific talent into our
SPORE and, more broadly, into sarcoma-relevant research. The specific aims of the
Developmental Research Program are: 1) to provide seed funding for innovative, investigator-
initiated research in the biology, pathogenesis, progression, and natural history of sarcoma, 2)
to fund research with exceptional potential to advance the translational research goals of the
SPORE. We are budgeting $400,000 yearly for this program including $50,000 from the SPORE
award itself and $350,000 in MSKCC institutional and philanthropic funds. The priority for
funding will be those initiatives considered most creative and of the highest scientific quality.
Preference will be given to projects that complement the long-term research goals of the SPORE
and advance our translational research objectives. The executive committee can also solicit and
fund experimental or clinical initiatives that address an urgent and specific need in the MSKCC
SPORE in Soft Tissue Sarcoma program or a unique research opportunity. The internal scientific
advisory committee will review applications to determine priorities for use of these funds and
will annually select projects for funding. Projects may apply for a second year of funding
through the same competitive process, and the projects that appear most promising will be
considered for incorporation into the SPORE as Research Projects, either in current or future
funding cycles.

Public health relevance
Developmental Research Program NARRATIVE The Developmental Research Program supports innovative research into soft tissue sarcoma, a group of cancers that cause death in approximately half of the patients who develop them. This program provides short-term funding so that the SPORE leaders can quickly learn whether a given line of research is likely to lead to better treatment for patients with sarcoma, or whether it is unlikely to improve treatment and resources should be directed elsewhere.